HUMAN INTESTINAL SECRETION AND EXCRETION OF ZINC

The goal of this proposal is to delineate the role of the small intestine in human zinc (zn) homeostasis, with special reference to post-prandial secretion-reabsorption of endogenous zn. This objective will be achieved by a combination of multi-lumen intestinal intubation/perfusion, stable isotope kinetic and model based compartmental analysis techniques. These techniques will be used for quantitative evaluation of zn homeostasis in the small intestine over a range of dietary zn intakes in normal subjects and in patients with cystic fibrosis (cf).